Global Breast and Cervical Cancer Control: Implementing a Bundled Screening Approach in a Resource Limited Setting

ABSTRACT
In Sub-Saharan Africa, 75% of women diagnosed with breast or cervical cancer are already in late-stage disease,
a much more dire figure than women in high income countries. One reason for this is a lack of programs for
cancer screening and early detection, which could be remedied by bundling breast and cervical cancer
screening, an innovative approach that is known to improve access to preventative cancer care and yield an
earlier cancer diagnosis, thereby decreasing its morbidity and mortality. Clinical Breast Exam (CBE) and the
“screen-and-treat” approach for cervical cancer via visual inspection with acetic acid (VIA) are effective screening
modalities and often the top choice in resource-limited settings. However, there is a critical gap in knowledge of
how to effectively implement and optimize these bundled interventions. The Cameroon Baptist Convention
Health Services (CBCHS) runs the largest and most comprehensive breast (CBE) and cervical cancer screening
(VIA and HPV testing) program in Cameroon by bundling both screenings into a single service. Through a long-
established collaboration between CBCHS and UAB researchers, there is now an opportunity to conduct
implementation science-driven research to optimize the screening program, improve the screening to diagnosis
to treatment cascade, and to effectively disseminate the program, thereby maximizing its public health impact.
Guided by the RE-AIM (Reach, Effectiveness, Adoption, Implementation, Maintenance) robust implementation
science framework, the proposed career development award aims to 1) establish the reach and effectiveness of
the bundled women’s cancer screening program and compare these metrics across stationary and mobile clinics,
2) identify the implementation outcomes of acceptability (patient level), appropriateness (provider level), and cost
(organization level) along with barriers and facilitators to program maintenance (organization level), and 3)
conduct implementation mapping via stakeholder (patients, providers, organizational leaders, Ministry of Health
personnel) engagement to devise a patient-centered multi-level implementation strategy(s) to enhance and
disseminate two bundled evidence-based cancer screening interventions into new clinic sites in the public health
system in Cameroon. To successfully complete the project, the PI will receive mentorship from a team of
experienced clinicians and researchers of health services, implementation science, and health economics. The
PI will also gain focused training via a personalized dynamic learning plan in implementation science, mixed
methods research, economic evaluation, and science of sustainability and scale. She will also participate in grant
writing workshops over the award period in order to prepare follow-on grant proposals to further her work in the
optimization of cancer control programs. Successful completion of the proposed research and training will
position the PI as an independent, NIH-funded surgeon-scientist focused on enhancing equitable global cancer
control by implementing innovative, scalable, and evidence-based interventions.

Public health relevance
Project Narrative: Sub-Saharan Africa carries a disproportionately high burden of advanced stage breast and cervical cancer. Lack of organized screening and early detection programs are one significant contributing factor to this phenomenon. This work leverages the rigorous methods and frameworks of implementation science to elucidate optimal implementation strategy(s) of bundling breast and cervical cancer screening into a single cancer control and prevention service in a resource limited setting (Cameroon).